NINDS CENTER FOR CLINICAL TRIAL RESOURCES

The Contractor shall provide scientific resources and services necessary to support for a broad range of activities required to support The National Institutes of Neurological Disorders and Stroke (NINDS) clinical research program effectively. This includes multiple activities requiring advanced expertise in the design, conduct, and oversight of clinical research. Although four distinct performance areas have been identified (see Specific Requirements), it is impossible to anticipate every need of the NINDS DCR because the future clinical research and their associated unique demands are unknown, and because of possible unanticipated NINDS and NIH policy changes. The Contractor shall provide clinical research professionals with broad enough expertise to handle such unanticipated needs. Examples of such possible needs include: preparation of the scientific background information needed to develop new scientific initiatives involving clinical research; and dissemination and translation of results from clinical research to the clinical community (patient and physician education). The mission of National Institute of Neurological Disorders and Stroke is to seek fundamental knowledge about the brain and nervous system and to use that knowledge to reduce the burden of neurological disease for all people.

The NINDS has identified four specific performance areas comprising the scope of work under the contract.

 PERFORMANCE AREA #1: QUALITY ASSURANCE/QUALITY CONTROL MONITORING SUPPORT
 PERFORMANCE AREA #2: STATISTICAL AND METHODOLOGICAL SUPPORT
 PERFORMANCE AREA #3: CLINICAL DATA ACQUISITION AND ARCHIVING SUPPORT
 PERFORMANCE AREA #4: COMMON DATA ELEMENTS SUPPORT

Public health relevance
Common data elements development, oversight of clinical trials, support for clinical research